Human Liver Tissue & Hepatocytes Research Resource (HLTHRR)

PROJECT SUMMARY/ABSTRACT
The overall goal of the Human Liver Tissue & Hepatocytes Research Resource (HLTHRR) program is to
provide normal human liver tissue and normal human hepatocytes (HC) and non-parenchymal cells (NPC)
including NPC sub-fractions (Kupffer cells, sinusoidal endothelial cells, cholangiocytes, and stellate cells) as a
core lab to biomedical researchers across the USA. Primary human hepatocytes (HC) continue to be the most
relevant cellular resource to model liver functions and advance our knowledge of mechanisms underlying
metabolic enzymes, drug discovery, toxicology, viral and alcoholic hepatitis, regeneration capacities, and most
importantly human liver diseases. The NIDDK has funded a research program for over 25 years to isolate and
distribute primary human hepatocytes (HC) and liver tissues for research purposes to academic scientists who
are primarily NIH-funded. The initial program was known as Liver Tissue Cell Distribution System (LTCDS),
and more recently (2022-2024) Human HC Isolation and Distribution (HHID) in Dr. Geller's lab at Pitt with
NIDDK bridge funding as an administrative supplement to our active P30 DK120531 “Pittsburgh Liver
Research Center” (PI-Monga). All human HC isolations have been at the University of Pittsburgh (Pitt) as the
core lab in the USA, and cells distributed to PIs throughout the country. In this HLTHRR proposal, Dr. Geller's
lab will continue to provide human liver tissues and normal human HC as a core service to NIH-funded
investigators throughout the USA. Also, as part of our HLTHRR proposal, NPC from normal human livers will
be separated into high-purity fractions of Kupffer cells (KC), liver sinusoidal endothelial cells (LSEC),
cholangiocytes, and stellate cells in Dr. Soto-Gutierrez's Pathology lab at Pitt. We will also develop and deploy
a website to facilitate all aspects of cell and tissue distribution. This will include PI registration, announcements
of tissue and cell availability, submission and tracking of cell requests, confirmation of shipping, quality
feedback, annual summary of HLTHRR progress and related publications. The HLTHRR is a unique and
extraordinary resource for the biomedical research community to accelerate liver translational research with
the potential to hasten breakthrough discoveries.

Public health relevance
PROJECT NARRATIVE (RELEVANCE STATEMENT) Liver diseases caused over 51,600 deaths in the USA in 2020 (American Liver Foundation). It is estimated that 25% of the adult population in the country has liver disease, with the most common diagnosis of fatty liver that includes nonalcoholic steatohepatitis (NASH), along with viral and alcoholic chronic liver disease. The liver also experiences hepatic ischemia/reperfusion injury during major liver surgery and liver transplantation, as well as liver damage during sepsis and other inflammatory disease states. Human liver tumor cell lines or animal liver cells are not good models to mimic primary human liver cell response to pathophysiologic disease states. Our overall goal of the Human Liver Tissue & Hepatocytes Research Resource (HLTHRR) program is to provide normal human liver tissue and normal human hepatocytes (HC) and non-parenchymal cells (NPC) including NPC sub-fractions (Kupffer cells, sinusoidal endothelial cells, cholangiocytes, and stellate cells) to biomedical researchers across the USA to study acute and chronic liver diseases to improve public health.